Role of Tspan5 in MHC I antigen presentation and cancer immune evasion

Abstract
CD8 T lymphocytes are the major mechanism by which the immune system eliminates cancers and virally
infected cells. CD8 T cells detect these abnormal targets by recognizing immunogenic peptides displayed on
MHC I molecules. Cancers and viruses can evade immune control by inhibiting MHC I antigen presentation,
making it harder for CD8 T lymphocytes to detect and kill these pathological cells. Therefore, it is important to
understand the mechanisms that regulate antigen presentation as well as the mechanisms by which tumors
dysregulate these processes - this is the overall goal of this proposal. Our proposal is based on our discovery in
an unbiased forward genetic screen of a Tetraspanin (Tspan5) that unexpectedly organizes MHC I molecules in
ways that amplify theair ability to stimulate CD8 T cell responses. Our 1st aim will elucidate the underlying
molecular mechanisms for this biological effect. This Aim will test the hypothesis that Tspan5 organizes MHC I
molecules into stimulatory membrane microdomains that by virtue of size, MHC I density and/or incorporation of
other key ligands markedly increases the efficiency of antigen presentation. Our 2nd aim will elucidate how, when
and where Tspan5-MHC I microdomains form. This aim will test the hypotheses that peptide-MHC I complexes
are incorporated into Tspan5 immunostimulatory microdomains upon release from the peptide-loading complex
in the ER, through specific molecular interactions with Tspan5 and other Tspan family members, and then these
immunostimulatory microdomains are trafficked to and maintained on the plasma membrane for display. Our 3rd
Aim is based on our finding that certain cancers, including renal cell carcinomas, significantly downregulate
Tspan 5 expression. The hypothesis underlying our 3rd Aim is that this loss of expression of Tspan5 is one of the
ways that cancers escape immune surveillance and control and thereby progress. A corollary of this hypothesis
is that the loss of Tspan5 is a mechanism that will influence resistance to immunotherapy; as such, Tspan5 could
provide a much-needed biomarker for identifying patients who will not respond to immunotherapy and could also
be a potential therapeutic target to restore responses to such therapy. Our experimental approach will use
isogenic Tspan5-edited renal cell cancers (loss of function and gain of function) in preclinical models with
humanized and wild type mice to define the role of Tspan5 in tumor immune evasion and responsiveness to
immunotherapy with checkpoint blockade for both human and mouse tumors. Finally, we will translate these
findings into human cancer patients by investigating whether Tspan5 expression is a biomarker that can predict
clinical course. Our hypotheses and feasibility of the proposed experiments are supported by strong preliminary
data. Taken together, our proposed experiments will go from basic mechanistic studies, which will elucidate a
potentially fundamental and novel mechanism for optimizing the ability of APCs to stimulate T cell responses, to
preclinical and clinical studies, which will define how loss of this mechanism affects immune control of cancers
and clinical outcomes.

Public health relevance
Narrative. This proposal seeks to elucidate how the immune system regulates its mechanisms that detect, control and eliminate cancers and virally infected cells. This is an important issue because this process is essential to a patient's ability to prevent and/or fight these diseases naturally or in the setting of immunotherapy. The information gained from the proposed studies may lead to a better ability to predict and/or manipulate immune responses to tumors and ultimately aid in the immunotherapy of cancers.